Hardship and Survival: The Impact of Migration-Related Trauma, Communal Coping, and Social Stressors on the Suicide and Mental Health Outcomes of Latina Immigrant Women

PROPOSAL SUMMARY
Migration is a social determinant of health which has profound and long-lasting health consequences, and
contributes to the significant disparities in mental health outcomes experienced by Latina immigrants. Shifts in
migration patterns from Latin America over the last decades – driven in part by sociopolitical conflict, organized
violence, and evolving gender norms – have contributed to unprecedented growth in the population of Latinas in
the US. Latina immigrants face cumulative exposure to an array of traumatic experiences before, during, and
after migration – including sexual assault, natural disasters, kidnapping, separation from/and death of family
members, and deprivation of basic needs. These are deeply traumatic experiences which are associated with
poor mental health outcomes (posttraumatic stress disorder, depression and anxiety). Presently, suicide is a
leading cause of death among Latinas in the U.S., but there is limited research seeking to identify the distinct
factors that heighten the risk of suicide and that promote resilience among Latina immigrants. Furthermore, there
is a significant gap in knowledge regarding Latina immigrant’s lived experiences with suicide and migration-
related trauma and understanding how these women utilize communal and cultural resources – such as
communal coping, collective rituals, and traditional gatherings – to cope with the collective impact of migration-
related trauma and chronic stress. This exploratory sequential mixed-methods study aims to generate a rich
understanding of the experiences of Latina immigrants with migration-related trauma, suicide and suicidal
ideation, and social stressors, and to identify salient cultural and communal factors that shape these experiences.
This will be accomplished through the following aims: 1a) explore how exposure to migration-related trauma,
communal coping, and social stressors influence the risk of suicidal ideation and mental health symptoms among
adult Latina immigrants (n=20) using individual interviews and focus groups; 1b) understand community
providers’ and team members’ (promotoras, nurses, and clinicians) (n=16-20) perspectives of how migration-
related trauma, communal coping, and social stressors impact the mental health outcomes of Latina immigrants
using focus groups; 2) examine how migration-related trauma, social stressors, communal coping and other
salient cultural, migratory, and communal factors impact suicidal ideation and mental health symptoms among
Latina immigrants using a cross-sectional survey; and 3) collaborate with community partners and the community
advisory board to interpret and integrate findings and identify risk and resilience factors that shape experiences
with suicide and the mental health outcomes of Latina immigrants. This innovative study builds on over a year
of preliminary work, including community engagement efforts, a systematic review of the literature and concept
analysis, and conceptual framework development. We center the cultivation of collaborations between the PI,
mentorship team, our community partners at Centro SOL, and the Latino(a) immigrant community in the
Baltimore Metropolitan Area. To our knowledge, this innovative proposal will be the first to explore the impact of
migration-related trauma (across the stages of migration), social stressors, communal coping, and other salient
cultural and communal factors on the mental health outcomes of Latina immigrants.

Public health relevance
PROJECT NARRATIVE This proposed study addresses aligns with NIMHD’s Research’s Strategic Plan, which highlights the crucial need to take life course and multi-level approaches to advance the science of minority health disparities through dissemination and implementation of novel scientific and community-driven approaches. Social determinants of health contribute to the disparate impact of migration-related trauma and suicide on Latina immigrants, and this innovative study will further inform our understanding of cultural resilience by exploring salient communal and cultural factors that have been less explored in this population. With an enhanced understanding of how migration-related trauma influences mental health symptom severity and risk of suicide in the context of salient cultural and communal resources, we will be better positioned to develop targeted trauma-informed, suicide- prevention interventions to promote health equity and the psychological wellbeing of Latina immigrants.